Integrated Islet Distribution Program (U24) - 2021

PROJECT SUMMARY / ABSTRACT
Human pancreatic islets are an essential research resource for research on the prevention, treatment, and
pathophysiology of diabetes mellitus. Recent data have highlighted important differences between murine and
human islets, substantiating the continued need for access to human islets, as the gold standard in diabetes
research. City of Hope (COH) is applying for this U24 renewal to remain as the Integrated Islet Distribution
Program Coordinating Center (IIDP CC) for the next 5 years, to continue to provide distribution of human
cadaveric islets and ancillary tissue for biomedical research to researchers worldwide. Our proposal leverages
the significant investment made by NIH over the last 19 years that has established and successfully maintained
the IIDP at COH. From qualification and auditing of high-quality Islet Isolation Centers (IICs), to forecasting,
tracking, and meeting the needs of investigators, since 2002 our experienced team has worked with 20 different
islet isolation laboratories to coordinate the distribution of over 330 million islet equivalents to more than 400
investigators across 16 countries since 2002, supporting 767 peer reviewed publications. Through this renewal
we will continue to subcontract with our 5 highly qualified IICs to isolate and distribute human islets and ancillary
tissue via our advanced electronic Islet Allocation System (IAS). We will continue to manage the review process
for islet receipt, pilot studies, and Opportunity Pool funding. We will further enhance our IAS to broadcast offers
online and notify approved waiting researchers of islet availability, in a fair, equitable and time sensitive manner.
IIDP will continue to maintain the existing cost recovery system through subscription fees collected from islet
researchers, which has garnered a total of $9,303,950 since the implementation of subscription fees to offset
the expenses of pancreatic processing for the IICs. We will continue to closely monitor and help to improve the
quality of islets distributed, through the continuation of the Human Islet Phenotyping Program (HIPP) that
conducts assays on a sample from each islet isolation. IIDP has just added a Human Islet Genotyping Initiative
(HIGI) to genotype each isolation as well. Phenotyping and genotyping data, as well as UNOS data, extensive
donor and islet isolation data, will be made available to approved investigators through online access to the IIDP
Research Data Repository, with IIDP and NIDDK approval of applying scientists. Investigators can easily search
the required data, select filter criteria, save their searches, and download the integrated IIDP data for exploratory
analyses. Through our proven state-of-the-art administrative, business, technical, statistical, quality assurance,
and informatics processes and tools, the accessibility of human islets for investigators conducting essential
diabetes mellitus research will be secured. We will continue to provide an indispensable research resource for
the diabetes research community by ensuring that the IIDP remains stable, technologically advanced, continually
enhanced, and fully responsive to the islet needs of the research community, promoting the next generation of
scientific experimentation toward the prevention and treatment of diabetes.

Public health relevance
PROJECT NARRATIVE Individuals with diabetes experience significant primary and secondary complications, costing an estimated annual $569 billion dollars of care in the United States for 34 million Americans, with annual average medical costs of $16,752 per person. The central importance of human islets in the pathology of this disease, and demonstrated use of islets as an unparalleled experimental and treatment resource, has led to continued demand for human islets from healthy donors, and an escalating demand for specific islet preparations from donors with Type 2 Diabetes and rare diseases. Maintenance of a large scale islet distribution network such as the Integrated Islet Distribution Program (IIDP) is critical to provide researchers with access to this precious resource, to advance discoveries and progress in the field of diabetes mellitus research.